Biostatistics Core

The primary purpose ofthe Biostatistics Core (Core D) is to continue to provide biostatistical expertise for the design and analysis of all the protocols contained in the Program Project Grant. The Specific Aims of Core D are: Aim I. Assist in the design of experimental protocols and insure the proper sample size is selected to provide reasonable power Aim II. Facilitate data transfer and data quality assurance for all projects Aim III. Analyze and interpret the results from data gathered from the experiments Aim IV. Assist in the preparation of statistical components of presentations, reports and manuscripts Aim V. Develop and disseminate new biostatistical approaches for the analysis of the data; and Aim VI. Participate in discussions and present statistical seminars As we have done in the past, every new experimental protocol will be written in conjunction with a biostatistician from Core D who will provide design expertise and sample size justification for the animal care protocol. Members of the Core will attend the weekly Department of Hypertension and Vascular Research staff meetings. This will facilitate introductions to new PPG staff and also enable the scheduling of biostatistical seminars to cover topics of interest. We anticipate that the efforts of the Biostatistics Core staff (50%) will be divided equally with all four projects contained in this application. We reiterate that the presence of a Core provides availability of a set of biostatisticians with dedicated time and multiple years of experience with the Program Project. This availability is essential to the continuing success of the grant. Although located in a separate building the Biostatistics Core staff are a short walk from the Hypertension and Vascular Research Division, always available by e-mail, and always available for face-to-face meetings to discuss project design and contribute to the preparation of both manuscripts and grants.

Public health relevance
RELEVANCE (See instructions): The presence of biostatistical expertise is synergistic with the scientific expertise of the investigators in the Program Project. Their presence improves the scientific output from the PPG.